Administration

Core A: Administration will serve as the Coordinating Center for the entire DIAN project. As such, the specific aims of Core A: Administration are as follows: 1. Organize and coordinate activities and communication of the Cores, subcontractors and clinical performance sites toward achieving the stated goals of DIAN, to include administrative, and budgetary support and monitoring, and problem solving on a continuous basis. 2. With the Clinical Core and the Clinical Coordinating Center, delineate protocols; establish, coordinate and monitor participant recruitment and retention. 3. With the Clinical Core, the Clinical Coordinating Center, the Genetics Core and the Informatics Core, organize and monitor data and tissue collection, and storage. 4. With the Steering Committee and subcommittees, establish policies and procedures regarding: protection of research participants; resource (data, images and tissue) sharing, dissemination, an publications; and future expansion of DIAN to include other sites and languages. 5. Organize and support the DIAN Steering Committee and its subcommittees to include arranging meetings, communication and execution of their decisions. 6. Arrange for periodic external review and advice concerning DIAN goals and progress 7. Arrange for and finance genetic counseling and testing services when desired, and participant travel when necessary for participation.